Mechanisms Regulating Cytomegalovirus

Human cytomegalovirus (HCMV) infects over half of all Veterans and threatens the lives of those with
impaired immune systems. HCMV is the leading infectious cause of birth defects. There is no HCMV
vaccine, and the antiviral drugs have problems with potency, toxicity, and drug-resistance. The long-range
goal of this research is to identify critical points in the viral transcription-DNA replication cycle that would
serve as new targets for therapeutic intervention. This proposal is based on the premise that our gap in
knowledge of how viral early transcription produces viral DNA replication and how viral DNA replication
results in viral late transcription limits our ability to design new therapeutic treatments for the viral disease.
By customizing advanced technologies and developing new tools, we have used integrated functional
genomics (dTag system, PRO-Seq, ChIP-Seq, genetically engineered test viruses, and promoter function
assays) to determine where and when Pol II initiates transcription, identify sites of viral transcription factor
binding genome-wide, and quantify change in Pol II nascent transcripts from individual promoters in relation
to core promoter sequences, transcription factor loss, stage of infection, and viral DNA replication. We find
that there are three distinct pathways to viral late transcription. Two of these pathways involve the HCMV
IE2 and late transcription factor (LTF) group members. The individual role of each of the 3 different IE2
isoforms (IE2-86, IE2-60, and IE2-40) in viral late transcription is unknown. The six-member set of LTFs
bind to Pol II and a DNA sequence signature in gene promoters, forming a preinitiation complex (PIC) that
drives transcription. Diversity in sequence signature pattern likely determines the amount of individual
promoter output. It is unknown precisely when and how the LTF complex assembles on viral promoters and
how the LTF assembly engages Pol II in transcription. Our use of a new high-resolution ChIP-Seq technique
and bioinformatics pipeline to map genomic locations of nucleosomes, as well as IE2 and LTF PICs,
suggests that LTF PICs occupy genome regions not occupied by nucleosomes. This new ChIP-Seq
technique will strengthen our integrated functional genomics approach to further determining the
mechanisms controlling viral promoter transcription in relation to chromatin structure. Our preliminary data
indicate that: 1) the early-late transcription switch lags many hours behind the onset of viral DNA replication;
2) the HCMV promoter population members that are active differs by cell type and condition, and this
difference may involve IE2 and LTF functions; and 3) the HCMV promoter population that is active during
viral reactivation in the NT2 model differs from that in acute productive infection. We will test the hypothesis
that HCMV transcription factors usurp host Pol II that navigates a modified chromatin environment suited to
bring about viral late transcription (Aims 1 and 2) and to coordinate the viral transcription program in diverse
cell types (Aim 2) and under cellular conditions supporting quiescent and reactivation infections in the NT2
model (Aim 3). We will apply a multifaceted approach to each of the specific aims to: 1) elucidate the
regulators of the early-late transcription switch, 2) determine the mechanistic basis for cell type differences
in viral transcription, and 3) determine how activation of quiescent infection changes viral transcription. Our
proposal integrates the expertise of the Meier and the Price labs in virology and transcription, respectively.
We will build on this productive collaboration to complete the proposed research plan. The discoveries
coming from these studies will identify generalizable features of gene regulation that pertain to other
members of beta- and gammaherpesvirus subfamilies, which include human herpesvirus 6 and the
oncogenic herpesviruses, Epstein-Barr Virus and Kaposis sarcoma-associated herpesvirus.

Public health relevance
Cytomegalovirus (CMV) infection takes a toll on the life and health of thousands of Veterans because the currently available antiviral drugs are woefully inadequate. The Institute of Medicine estimates an annualized healthcare cost savings of $1-4 billion if CMV infection could be prevented. A CMV vaccine that effectively prevents infection is unlikely to be realized in the next decade. Thousands of Veterans already have CMV within them that has re-activated from dormancy to produce disease. This motivates a search for alternative ways of blocking CMV infection. Our research goal is to deactivate CMV before it starts replicating. By studying how CMV activates its gene expression program for replication, we aim to identify vital targets susceptible to precision-guided pharmacologic agents that effectively neutralize the virus. We will also discover previously unknown mechanisms of gene expression control that is broadly relevant to other viruses and many human diseases.